Mitigation Strategies for Metabolic Syndrome-induced Bioprosthetic Heart Valve Degeneration

SUMMARY
Bioprosthetic heart valves (BHV), made from glutaraldehyde-fixed xenografts, are widely used for surgical
(SAVR) and transcatheter valve interventions (TAVR), but suffer from limited durability due to Structural Valve
Degeneration (SVD). Advances in BHV device engineering and delivery have created the possibility to provide
state-of-the-art care to heart valve disease patients that were once deemed inoperable due to their risk score
and advanced co-morbidities. However, the same class of devices is offered to all patients, irrespectively of their
co-morbidities and susceptibility to structural valve degeneration. Metabolic syndrome (MetS) is a common
comorbidity in patients who require BHV and is a known risk factor for cardiovascular diseases. Our published
and preliminary results show the enhanced susceptibility of bio-implantable materials to oxidation, glycation, pro-
calcific proteins, and crosslinkers in patients with Metabolic Syndrome or rodent model of MetS, using Zucker
Diabetic Fatty (ZDF, Obese fa/fa). We have also shown that poly-2-methyl-2-oxazoline (POZ) functionalization
of clinically graded BHVs and bovine pericardium mitigates SVD by reducing protein absorption, decreasing
glycation, and oxidation products accumulation, and enhancing thromboresistance. Notably, POZ
functionalization reduces calcification using human serum-incubation assays and subcutaneous implants in ZDF
rats. In MetS patients, both surgical (SAVR) and percutaneous (TAVR) approaches are valid treatment options,
although some recent studies raise the possibility that, in the long term SAVR could exhibit higher survival rates.
Finally, given their conditions, MetS patients are often pharmacologically treated to control hyperglycemia and
high-density lipoprotein cholesterol. Therefore, SVD - in the clinical setting of Metabolic Syndrome - is driven by
three main factors: a) the biochemical profile of the patients, b) device selection and the susceptibility of the
implanted material to degradation, and c) the pharmacological treatments that MetS patients are receiving. This
application will address these three aspects and test the hypothesis that a combination of POZ-modified surgical
or transcatheter bioprosthetic valve and pharmacological management of MetS is needed to mitigate SVD and
improve durability. Once completed, the expected outcomes are to identify the main driving factors responsible
for the accelerated structural degeneration and calcification of implantable materials in patients with MetS.

Public health relevance
NARRATIVE The goal of this application is to improve the durability of Bioprosthetic Heart Valves thus reducing the need for multiple cardiac re-operations in patients with advanced Metabolic Syndrome. Our lab discovered this cohort of patients has an enhanced accumulation of pro-calcific, pro-oxidation, and pro-glycation markers resulting from their altered blood biochemistry. Since we have discovered that POZ reduces calcification and SVD using MetS sera incubation assays and MetS animal model, here we propose to identify the main driving factors responsible for the accelerated structural degeneration and calcification of implantable materials in patients with MetS and to assess POZ as MetS-specific mitigation strategy